Evaluating a multi-modal maternal infant perinatal outpatient delivery system: A randomized controlled trial (MOMI PODS RCT)

United States (US) pregnancy-related mortality (PRM) has more than doubled over the last two decades, with an additional 1.5-fold post-pandemic rise. It’s estimated that 80% of US PRM is preventable, yet rates remain high. Roughly half of US PRM occurs postpartum (PP) after hospital discharge. During this period, cardiometabolic and mental health conditions are precipitating factors in most deaths. Such data is particularly alarming considering that only 60% of patients receive healthcare during the PP year and few patients receive care that is adherent to evidence-based guidelines, particularly after pregnancy affected by a cardiometabolic or mental health condition. This is perhaps not surprising considering that patients consistently report that, “after you have [a] baby, it’s all about the baby and you don’t have time for yourself.” And providers consistently report that the obstetric to PP primary care hand-off is challenging. In collaboration with the Ohio Department of Medicaid, we designed a novel dyadic mother-infant PP primary care program targeted toward Medicaid-insured patients transitioning out of high-risk pregnancy – the Multi-modal Maternal Infant Perinatal Outpatient Delivery System (MOMI PODS). Dyadic care is a critical component of the model, with mothers and infants cared for in tandem throughout the PP year, and beyond. MOMI PODS was also strategically designed to 1) facilitate a coordinated obstetric to PP primary care transition, 2) promote tailored, evidence-based care informed by the obstetric history, and 3) integrate clinical and supportive care to concurrently address clinical and psychosocial needs. We have now established 8 MOMI PODS sites and delivered MOMI PODS to >300 dyads. Our compelling preliminary data shows that MOMI PODS is feasible and acceptable, with patients attending 95% of visits that systematically incorporate clinical and supportive care. In the MOMI PODS hybrid type 1 randomized controlled trial (RCT), we will evaluate the effectiveness of MOMI PODS in mitigating PP cardiometabolic and mental health risk, identify the biopsychosocial mechanisms linking MOMI PODS to PP health, determine if MOMI PODS promotes consistent PP care delivery, and identify strategies to improve implementation. Our central hypothesis is that MOMI PODS will mitigate PP risk for all by improving risk profiles and facilitating access to evidence-based clinical and supportive care. Thus, the MOMI PODS RCT represents a critical step toward establishing a consistent, scalable model of integrative PP clinical and supportive care that is capable of mitigating PRM risk for all. MOMI PODS has significant potential to serve as a foundational model of care appropriate for scale up and replication across a range of healthcare settings.

Public health relevance
PROJECT NARRATIVE In the United States, deaths related to pregnancy have more than doubled over the last twenty years, with an additional rise after the COVID-19 pandemic. To address these alarming trends, we designed a program that delivers care to mothers and infants together and provides multiple types of support during the year after pregnancy – the Multi-modal Maternal Infant Perinatal Outpatient Delivery System (MOMI PODS). In this trial, we’ll determine if MOMI PODS improves heart, metabolic, and mental health among new mothers and study how this may occur and how we can improve the program to better meet patient and family needs.